NE-CAT: A Resource for Advanced Macromolecular Crystallography

The main goal of NE-CAT is to provide user access to state-of-the-art synchrotron beamlines for
macromolecular crystallography. NE-CAT began planning and design for two beamlines in 2001. Beamline
24-ID-C became available to Advanced Photon Source users in 2006 and beamline 24-ID-E became
available in 2007. During the ensuing years, beamline improvements have resulted in stable, small X-ray
beams ideally suited for challenging problems in macromolecular crystallography. Each beamline is
equipped with a high capacity sample automounter and a microdiffractometer. Beamline 24-ID-C features
an EIGER2 X 16M pixel array detector, and 24-ID-E features an EIGER X 16M. NE-CAT provides
automated software for data collection and analysis (RAPD) and a web-based interface for remote data
collection. We will continue to provide routine maintenance to ensure efficient and reliable data collection,
and we propose an upgrade program to maintain state-of-the-art capabilities over the five years covered by
this application. This period includes 12 months without X-rays required for the APS upgrade project. We
will use this superb opportunity to rebuild a nearly 20-year-old system to be leaders in the field for another
20 years. NE-CAT has an experienced and dedicated scientific staff who enable access to the beamlines.
The staff is available or on call 24/7 to assist users with data collection and processing needs. This highly
regarded staff is a major strength of NE-CAT. NE-CAT has an outstanding record of reliability with technical
problems rarely interfering with user access. NE-CAT is directed by Dr. Steven Ealick, who has more that
30 years of experience overseeing the operation of synchrotron facilities for macromolecular
crystallography. The technical group, led by Deputy Director Dr. Malcolm Capel, and the operations group,
led by Associate Director Dr. Frank Murphy work closely together to ensure that the needs of the user
community are met. Together, these three individuals make up the NE-CAT management team. NE-CAT
beam time is in high demand, and each run all available beam time is allocated to users. NE-CAT typically
hosts more than 1500 users per year from about 160 unique user groups, either on site or remotely. NE-
CAT users published about 200 papers during the last year and are projected to publish more than 190 in
2021. NE-CAT’s record of productivity places it among the top of worldwide facilities for macromolecular
crystallography. NE-CAT operates an extensive user training program adaptable to first time users,
advanced users with technically challenging problems, and everyone in between. A website is available to
provide all information needed by new or current users. NE-CAT participates in many training and outreach
activities including organization of an annual workshop and participation in professional society meetings.
The staff works closely with user groups and are often invited to coauthor manuscripts resulting from user
support and training.

Public health relevance
The purpose of NE-CAT is to provide the biomedical community with access to state-of-the- art facilities for macromolecular crystallography. NE-CAT will enhance our ability to visualize the three-dimensional structures of biological macromolecules. These structures allow us to better understand basic biological systems, often resulting in the identification of new pharmaceutical targets and aiding in the development of new pharmaceutical agents. 1